PTEN and gut epithelial physiology

Project Summary
PTEN is classically considered a lipid phosphatase. Hence, loss of PTEN perpetuates the PI3K-Akt signaling to
promote cell proliferation, causing pre-clinical dysplasia or tumor. On the other hand, emerging evidence
suggests that PTEN has a protein phosphatase activity to regulate the phosphorylation at Ubiquitin protein. In
this project, we suggest that PTEN regulates the ubiquitination of Snail/Slug transcription repressor proteins and
the autophagy pathway in intestinal epithelial cells (IECs). PTEN deficiency elevates the ubiquitination of
Snail/Slug. By lowering YKT6, PTEN deficiency also suppresses autophagosome-lysosome fusion to inhibit
autolysosome formation. Then, aborted autolysosomes cannot degrade ubiquitinated Snail/Slug, leading to
augmented Snail/Slug repressors. Consequently, it represses the cell-junction protein expression, disrupting the
cell-cell junction and segregating the IEC from the intestinal epithelium. Regarding the role of PTEN in
tumorigenesis, previous studies suggest that loss of PTEN gene alone cannot cause tumor development in the
intestine. Indeed, IEC-target Pten knockout (KO) (PtenΔIEC/ΔIEC) mice do not develop tumors in the intestine.
However, we observed that PtenΔIEC/ΔIEC mice have enhanced cell growth and pre-clinical dysplasia in the
intestine. Human colon cancer tissues have reduced expression of PTEN and MYD88 (a key immune regulator)
compared to normal tissues. Accordingly, PtenΔIEC/ΔIEC mice develop massive intestinal tumors and metastasis
when combined with Myd88-KO. Therefore, our overall hypothesis is that (1) PTEN deficiency can induce pre-
clinical dysplasia, but an immune surveillance mechanism restrains its tumorigenic potential in the intestine. (2)
If an immune mechanism is compromised, it unleashes the tumorigenic potential of the PTEN deficiency. In
parallel, (3) PTEN deficiency can disrupt the cell-cell junction, allowing the segregation of dysplastic cells from
the epithelium. Further, a segregated dysplastic cell migrates to an extra-intestinal organ, developing tumor
metastasis. Based on the hypothesis, this R15 application proposes two major research aims: Aim 1 investigates
the non-classical function of PTEN in IECs. Aim 2 tests a potential intervention to prevent PTEN-promoted
tumorigenesis and metastasis.

Public health relevance
Relevance to Public Health This project investigates how loss of PTEN gene disrupts the intestinal epithelium, thereby resulting in pre-clinical dysplasia, tumor development, and subsequent tumor metastasis. This project will provide crucial information in developing new therapeutic measures against leaky gut and colon cancer.